LIPOPROTEINS IN DIABETIC MACULOPATHY

This study is designed to determine whether modification of lipoproteins which occur in the presence of diabetes may be associated with maculopathy, a common cause of visual impairment in elderly diabetic patients.